Multicenter study of sleep &outcome in high risk infants

Goal is to develop a prediction model of biological and social risk factors in neonates with less severe, more pervasive brain disorders. The specific aims are: 1) to investigate if medical complications predetermine dysmature EEG sleep. 2) to investigate if dysmature neonatal EEG results in changed sleep ontogeny in infants. 3) to determine if environment and social factors result in greater EEG-Sleep dysmaturity. 4) to determine if EEG/Sleep dysmaturity during infancy better correlates with lower developmental scales. EEG sleep studies are performed in a quiet room on the GCRC.